Model-Based Analysis of Brain Stimulation and Recording

PROJECT SUMMARY
Intracranial recording and stimulation of the human brain are powerful clinical tools that form the basis of wide-
ranging neuromodulation therapies. However, for all of the clinical successes of technologies like deep brain
stimulation (DBS), numerous scientific questions remain unanswered on the underlying biophysics that dictate
the clinical responses. Therefore, the goal of this project is to apply the latest advances in computational
modeling to analysis of the highest quality and highest impact clinical research datasets. The key questions
we plan to address are: 1) What do we record from the electrodes?, and 2) What do we stimulate with the
electrodes? The general approaches we plan to use include: 1) Patient-specific field potential models, which
are coupled to experimental electrophysiology recordings, to dissect the neural activity patterns underlying the
signals, and 2) Patient-specific pathway-activation models, which are coupled to quantitative behavioral and/or
electrophysiological measurements, to dissect the neural pathways that are directly stimulated and
subsequently responsible for the behavioral effects of stimulation. We then use knowledge gained from those
analyses to support the integration of advanced scientific datasets into the prospective surgical planning of
electrode(s) placement in clinical studies that are focused on developing new neuromodulation therapies
and/or testing novel device technology. These surgical planning efforts are facilitated by our interactive group-
based holographic visualization framework, HoloSNS. As such, the overall goal of our work is to directly link
the worlds of basic neuroscience and clinical neuromodulation, via detailed computational models, to better
understand stimulation and recording in the human brain.

Public health relevance
PROJECT NARRATIVE Intracranial recording and stimulation of the human brain are powerful clinical tools that form the basis of wide- ranging neuromodulation therapies. However, for all of the clinical successes of technologies like deep brain stimulation (DBS), numerous scientific questions remain unanswered on the underlying biophysics of recording and stimulating from the electrodes. Therefore, the goal of this project is to apply the latest advances in computational modeling to analysis of the highest quality and highest impact clinical research datasets.